Non-linear Optical Collagen Cross-linking (NLO CXL) for Treatment of Keratoconus

Project Summary/Abstract
Collagen crosslinking (CXL) using single photon, 380 nm, UVA light to photoactivate riboflavin (Rf) is
known to induce a two-fold increase in collagen stiffness and 1-3 diopters of corneal flattening. While these
effects have been shown to have significant therapeutic benefits for both treating Keratoconus and correcting
minor refractive errors, there are several major drawbacks to this procedure, including post-operative pain and
and delayed visual recovery with increased risk of bacterial infection and corneal scaring. In our recently
completed, NEI funded research project we developed a two-photon, nonlinear optical (NLO) CXL approach
using infrared femtosecond laser (FS) light that limits Rf photoactivation to the two-photon focal volume of an
objective lens. This device uses an amplified FS laser to generate 760 nm, 0.3 μJ pulses at less than 46.1
mW total power (under the ANSI thermal limit for laser eye exposure), and can crosslink a 4 mm diameter area
in less than 4 min, significantly enhance stromal stiffness 1.6 fold, and induce 1 to 2 diopters of corneal
flattening in live rabbits. As part of this project, we have also developed a novel, FS laser based, corneal
epithelial micromachining approach to create Microchannels (MicroCh) through the epithelium to greatly
enhance transepithelial (TE) Rf diffusion. Goal of this project is to test the hypothesis that post-operative pain
and delayed visual recovery is due to the excessive cellular damage caused by UVA CXL and that TE-NLO
CXL shows significantly less cell damage with faster visual recovery. This hypothesis will be tested through
the following specific aims: Aim 1. Optimize MicroCh TE Rf stromal penetration by determining the effects of
pulse energy, density and depth on Rf stromal concentration and epithelial/stromal integrity as compared to
other excipient TE approaches using ex vivo rabbit eyes. Aim 2. Determine the effects of TE Rf penetration
on corneal epithelial and stromal integrity comparing MicroCh to optimal excipient Rf approaches identified in
SA1 using an ex vivo rabbit eye model to measure epithelial/stromal cell death and induced inflammatory gene
expression at 3 hours and 24 hours with and without UVA or NLO CXL. Aim 3. Determine the effects MicroCh
Rf delivery and UVA versus NLO CXL in live rabbits by assessing the effects on epithelial integrity, corneal
sensitivity, stromal inflammation, wound healing and visual recovery.

Public health relevance
Project Narrative The major objectives of this renewal research application are: 1) identify the underlying mechanisms leading to adverse outcomes following corneal collagen crosslinking (CXL) using ultraviolet light (UVA) and riboflavin (Rf), and 2) develop alternative strategies that provide safer and more effective CXL for the treatment of corneal ectasia and refractive errors.